Neuroimaging of Visual Attention in Aging

Previous neuroimaging research suggests that age-related decline in the functioning of specific neural
systems contributes to decline in cognitive performance, even in the absence of significant disease. Previous
imaging studies, however, have typically focused on the magnitude of mean activation, rather than functional
connectivity (FC) of activated regions, and have relied on extreme-group designs comparing younger and older
adults. Building on the findings from the previous project period, we propose to investigate age-related
differences in visual attention with a multimodal imaging methodology comprising both resting-state and task-
related FC, as well as white matter integrity as assessed by diffusion tensor imaging (DTI). Each of four
experiments will include 90 healthy, community-dwelling adults sampled continuously across the age range of
18-79 years. Critically, the research will use graph theoretical analyses of structural connectivity (SC) and FC,
which will provide a unifying methodology and specific metrics (e.g., strength of FC within and between
network modules) that can be applied to both structural and functional imaging.
Each of the four experiments will involve a visual search task, and behavioral assessments of visual
search performance will implement a mathematical model of reaction time that yields separate parameter
estimates for the rate of information accumulation towards a decision (drift rate), as distinct from visual
encoding and response execution processes (nondecision time). We propose to elicit differential engagement
of functional modules, by varying the attentional demands of the search task related to: the enhancement of
target information versus suppression of irrelevant but salient information (Exp. 1), the spatial selectivity of
attention (Exp. 2), the activation of a motor response (Exp. 3), and the response to visually degraded targets
(Exp. 4).
Graph theoretical analyses of the structural and functional imaging data will test the overall scientific
premise of this project: that aging is associated with a shift in the dynamic balance of within-module and
between-module task-related FC (Aim 1), that this pattern is related to the degradation of visual information as
reflected in SC and FC of visual sensory regions (Aim 2), and that task-related FC will reflect the participation
of specific modules as a function of attentional task demands (Aim 3). We expect an age-related decline in the
graph theoretical measures of within-module connectivity, but an increase with age in measures of between-
module connectivity. Further, we hypothesize that the increase in between-module FC with age will be more
prominent during task performance, relative to a resting-state, reflecting older adults’ increased reliance on top-
down attention to support task performance. The four studies and associated network analyses, with healthy
adults, are designed to improve current theories of neurocognitive aging and provide information relevant for
diagnosis and treatment of neurodegenerative disease.

Public health relevance
This research will yield new, empirical data, from structural and functional brain imaging, regarding age- related differences in the neural mechanisms of attention, in the context of visual search and discrimination tasks. This research will be relevant to the public health by obtaining new information regarding age-related differences in healthy individuals, which is a necessary basis for the development of procedures for diagnosing and treating age-related cognitive impairment and neurodegenerative disease.